Identifying and disabling new pathways for macromolecular recycling in pancreatic cancer

PROJECT SUMMARY/ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) is an incurable malignancy with an overall median survival of 11
months post-diagnosis. PDAC develops in an oxygen-poor, nutrient-deprived microenvironment.
Consequently, PDAC cells and tumors are highly dependent on enhanced lysosome biogenesis and
activity to facilitate degradation, clearance and recycling of macromolecular substrates delivered by increased
rates of autophagy and micropinocytosis. Recent studies show some beneficial effects of combination
therapy with general lysosomal inhibition (hydroxychloroquine) in prolonging PDAC patient survival. However,
to effectively target the lysosome in this cancer we must first identify key PDAC-specific lysosomal factors
that enable pro-survival catabolic activities unique to this tumor and its growth pattern, and which could
be targeted with precision medicine approaches. Our labs implemented a systematic proteomic-
based analysis of lysosomes immunopurified from PDAC versus non-PDAC 2D cultured cells and in
vivo PDAC tumors to generate a comprehensive map of PDAC-specific lysosomal proteins at primary as
well as secondary organ sites. These studies highlighted two lysosomal hydrolases as essential for PDAC
growth. Phospholipase B domain containing 1 (PLBD1), a putative hydrolase of unknown function, is
upregulated in PDAC tumor specimens, and its ablation leads to massive morphological and functional
disruption of PDAC lysosomes, suppressing tumor growth under all paradigms. A second PDAC-specific
hydrolase was Legumain (LGMN), which was enriched in lysosomes of PDAC cells growing in the liver, a
major secondary colonization site but not the pancreas. Accordingly, depleting LGMN suppresses liver
colonization by PDAC cells without affecting their growth in the pancreas, pointing to LGMN as the first
organ site-specific lysosomal factor for PDAC growth. Building on these foundational discoveries, we will:
1- explore PLBD1’s role as an aminopeptidase that removes branched-chain amino acids (BCAAs) from
substrates, affecting PDAC cell metabolism. We will use mass spectrometry to identify PLBD1-dependent
substrates and investigate how their breakdown supports PDAC growth. 2-dissect how the LGMN enable
metastatic growth of PDAC in liver, particularly how breakdown of liver-specific macromolecular
substrates by LGMN fuel PDAC metabolism as well as the mechanisms that promote LGMN expression in this
organ. 3- develop small-molecule inhibitors for PLBD1 and LGMN via both covalent and non-covalent
chemistry to evaluate their potential as therapeutic targets in PDAC. Together, these studies will uncover key
lysosomal proteins supporting PDAC growth and suggest new therapeutic strategies targeting lysosomal
functions.

Public health relevance
PROJECT NARRATIVE Pancreatic ductal adenocarcinoma (PDAC) is a highly lethal cancer that thrives in a nutrientdeprived, oxygen- poor environment. We identified two critical lysosomal hydrolases, PLBD1 and LGMN, which are essential for PDAC growth and metastasis, with PLBD1 disrupting lysosomal function when ablated and LGMN being crucial for liver colonization. This proposal will explore how the degradative functions of these hydrolases promote PDAC survival, growth and metabolism, and will develop targeted inhibitors, potentially pointing to new therapeutic strategies.